Social influences on sexual health among Latinx adolescents and emerging adults who identify as LGBTQ+ in an agricultural community

PROJECT SUMMARY/ABSTRACT
Rates of sexually transmitted infections (STIs) in California have reached epidemic levels that exceed national
rates. Half of these infections occur among youth ages 15–24, and rates are disproportionately higher in sexual
and gender minority (SGM) adolescents and young adults (AYA). Latine SGM AYA have been shown to have
worse mental, physical, and sexual health outcomes than non-SGM AYA and have experiences of
discrimination including racism and homophobia. Yet, research is lacking on the experiences of Latine SGM
AYA who reside in rural settings who may have increased concerns around confidentiality and stigma in their
communities. This critical gap in evidence has impeded the development of interventions to address the needs
of rural Latine SGM AYA to increase their access to preventative sexual health services. The overarching goal
of this supplement is to understand social, cultural, and structural influences (social determinants) on sexual
health among rural Latine SGM AYA, such as those who identify as lesbian, gay, bisexual, transgender, queer,
intersex and other genders or sexualities (LGBTQI+) in emerging adulthood (ages 18–21). This study will be a 1-
year research supplement to the A Crecer cohort study (R01HD075787). The parent study follows a cohort of
adolescents from age 13 into young adulthood at age 21 in Salinas, California, to understand the social factors
that affect sexual health among Latine AYA. In the proposed supplemental study, we will analyze existing data
and conduct supplementary data collection by recruiting an additional 50 SGM AYA from the study area through
community organizations that serve this population. Currently, about 20% (n=73) of the cohort identifies as
SGM. This supplementary data collection will allow us to compare sexual health outcomes by SGM identity and
to better understand the experiences of SGM AYA in this area. In Aim 1, we will characterize disparities in
sexual health outcomes associated with SGM identity in emerging adulthood. Sexual health outcomes include
preventing pregnancy and/or STIs, accessing sexual health services, condom use, dating violence, and
satisfaction in sexual relationships. We will analyze quantitative data already collected from the A Crecer Phase
2 cohort and include the supplementary sample to characterize disparities in sexual health outcomes. In Aim 2,
we will explore AYA identity development and socio-cultural influences on SGM AYA’s experiences with their
sexual relationships, health, and well-being. We will conduct in-depth interviews (~20) with purposively selected
SGM AYA to understand their needs for and experiences in caring for their sexual well-being as well as
perceived socio-cultural influences on their sexual health and how that has shifted over time as their identity has
developed. Our established infrastructure, partnerships, and existing cohort position us for efficient initiation and
rigorous implementation of the proposed supplemental study. The focus on disparities in emerging adulthood
constitutes a high-priority and often neglected developmental period with opportunities to address gaps in
understanding ways to support transitions to adulthood that promote well-being and positive sexual health.

Public health relevance
PROJECT NARRATIVE Latine sexual and gender minority (SGM) adolescents and young adults (AYA) have been shown to have worse mental, physical, and sexual health outcomes than non-SGM AYA, but research is lacking on the experiences of Latine SGM AYA who reside in rural settings who may have increased concerns around confidentiality and stigma in their communities. This research supplement adds additional quantitative and qualitative data collection with SGM AYA to an ongoing study that has been designed to examine the effects of multiple social determinants on sexual health in Latine AYA in an agricultural setting in California. The proposed research will fill a critical gap in literature regarding disparities in sexual health outcomes for Latine SGM AYA residing in rural areas and by deepening our understanding of structural factors that limit or promote sexual health in this population to ultimately increase Latine SGM AYA’s well-being and positive sexual health.